Full Project 3

ABSTRACT – FULL PROJECT 3 ADM
Pancreatic ductal adenocarcinoma (PDAC) remains one of the most devastating cancers with poor prognosis
and rising incidence. To combat this deadly disease, we should direct our efforts towards preventing PDAC or
halting the progression of precursor lesions to invasive disease parallel to developing novel treatments. One of
the earliest known initiating events for PDAC is the process of acinar-to-ductal metaplasia (ADM). Understanding
and reduction of ADM formation may reduce early PDAC development and progression. Blacks display a
significantly increased incidence and mortality from PDAC compared to other races for unknown reasons. The
role of race on pancreatic ADM and its contributions to the development and progression of PDAC need to be
addressed. In our previously funded CaRE2 Pilot Project, we used normal pancreatic acinar tissues from Black,
White and Hispanic donors to study the impact of race on acinar-to-ductal metaplasia (ADM) and found that
Blacks undergo ADM to a greater extent than Whites or Hispanics. In this proposed Full Project as part of the
CaRE2 renewal, we will expand on and extend our previous pilot project by including diseased tissues from CP
and PDAC from White, Black, and Hispanic donors since accumulating evidence suggest that chronic
pancreatitis (CP) is a major precursor to the development of PDAC. We will investigate the impact of race on the
cellular and molecular events regulating the interplay between ADM and the microenvironment. Guided by our
published and unpublished results, we hypothesize that the racial disparities seen in PDAC are related to
differences in how the pancreas microenvironment develops during ADM, which means that ADM and its
surrounding microenvironment can be used as a target to treat PDAC. We propose the following specific aims
to address this hypothesis: Aim 1: The influence of race on ADM of healthy pancreas, CP, and PDAC-associated
acinar tissues. Aim 2: The roles of pancreatic stellate cells and macrophages in ADM and ADM reversal Aim 3:
Contributions of the race to ADM reversal and cell heterogeneity. The proposed studies will impact the field of
pancreatic cancer by providing a missing link between disparities, ADM, tumor microenvironment, and potential
treatments for CP and PDAC. The specific focus on the racial contributions of microenvironment remolding
during pancreatic metaplasia aligns with the Florida-California Cancer Research, Education and Engagement
(CaRE2) Health Equity Center’s overall goal to eliminate cancer health disparities among Black and Latino
individuals in California, Florida, and across the U.S.